CBEC-KEMRI BIOETHICS TRAINING INITIATIVE

1 ABSTRACT
2 Low- and Middle-Income Countries (LMICs) like Kenya and Pakistan face a double burden
3 of disease. This was escalated by the Covid-19 pandemic which enhanced inequity,
4 exploitation and inaccessibility to research outputs. The Covid pandemic also diversified the
5 research portfolio and Research Ethics Committees (RECs) in such settings grappled with
6 uncertainty while providing oversight to novel research initiatives. The growing number of
7 institutions of higher learning in Kenya and large number of institutions in Pakistan with both
8 social sciences and biomedical faculties emphasize the need to enhance human subject
9 protection and build capacity for both training and research in bioethics. To address current
10 and emerging ethical challenges, we propose diversification of the existing South to South
11 collaboration, between the Kenya Medical Research Institute (KEMRI) and the Centre for
12 Biomedical Ethics and Culture (CBEC). Building onto the work done in the past five years,
13 the CBEC-KEMRI Bioethics Training Initiative (CK-BTI) will establish the first blended
14 bioethics PGD and Masters level programs at 2 local Kenyan universities. To achieve
15 sustainability and to ensure the timely completion, CK-BTI will provide faculty for both
16 programs, and conduct training in ethics pedagogy including development of teaching and
17 examination tools while also providing training in mentorship. This will also a ensure a critical
18 mass of well-trained faculty for the two new Kenyan programs and spill over to support other
19 graduate level bioethics training programs which are currently being established in both
20 Kenya and Pakistan. Capacity building for other stakeholders including RECs members and
21 researchers in Kenya will be achieved by expanding the number of certificate courses
22 offered every year and introducing a new training to target lay members of REC. Rapid
23 capacity building initiatives including workshops in research ethics and research
24 methodology will also be introduced in Pakistan. Finally to support and grow leaders in
25 global bioethics in both countries, workshops to develop skills in grantsmanship and
26 publication will be held to expand bioethics research output. This contextual needs-driven
27 multi-pronged program ultimately seeks to enhance quality of research and enhance human
28 subject protection in resource-constrained settings.

Public health relevance
Narrative The proposed program will establish the first blended Masters and Postgraduate Diploma training in bioethics in Kenya at 2 local universities. The program will also build capacity of both Kenya and Pakistan-based faculty to support these graduate-level training programs by offering focused trainings in bioethics pedagogy, mentoring, and scientific writing including grantsmanship and manuscript development. Rapid capacity building initiatives will involve training stakeholders from both countries in basic and emerging issues in research and public health ethics through workshops and certificate courses, with a focus on enhancing human subject protection, especially in resource-limited settings.